Intervertebral Disc Mechanics with Functional GRASP-MRI

PROJECT SUMMARY
Low back pain (LBP) is a major clinical and socioeconomic global health burden. In fact, LBP affects nearly all
of us at least once in our lives, and in ~20% the condition becomes chronic. The intervertebral disc (IVD) consists
of a proteoglycan (PG)-rich nucleus pulposus (NP) surrounded by a collagenous annulus fibrosus (AF) that
together provide support, transmit complex loads and motion of the spine. With aging, the IVD undergoes
progressive and irreversible degenerative changes that often lead to LBP. Several techniques have been utilized
to characterize the IVD, using animal or human cadaver models. While these studies can provide important data,
internal disc mechanics may have different characteristics and quantifying the behavior of internal disc
mechanics is technically challenging for in-vivo applications in humans. Therefore, we hypothesize that MRI
studies of the lumbar IVDs performed under different static mechanical loading states (e.g., rest, during loading
and recovery), using a flexible dynamic Golden-angle Radial Sparse Parallel (GRASP) MRI technique, could be
used to better quantify disc mechanics in-vivo.
The overarching goal of this R21 proposal is to develop a framework for non-invasive evaluation of in-vivo lumbar
IVD mechanics (e.g., strain mapping in L1/L2-L5/S1) in response to MRI-compatible mechanical loading. For
this purpose, we will utilize a fast, flexible dynamic Golden-angle Radial Sparse Parallel (GRASP)-MRI
acquisition, for quantitative assessment of biomechanical characterization of lumbar IVDs on a standard clinical
3T scanner in a clinically feasible scan time, employing compressed sensing (CS), parallel imaging (PI), golden
angle radial sampling and an optical flow algorithm.

Public health relevance
PROJECT NARRATIVE The current R21 proposal will establish a non-invasive imaging of intervertebral disc strain mapping in the lumbar spine based on a fast, flexible dynamic volumetric GRASP-MRI sequence.